Clinical and Translational Science Collaborative of Northern Ohio, Systems Marketing Analysis for Research Translation (SMART) Innovation Program

PROJECT ABSTRACT
The Systems Marketing Analysis for Research Translation (SMART) Innovation Program brings a cutting-
edge set of tools together to improve clinical and translational research effectiveness, efficiency, and equity
and thereby enhance public health and health care delivery. The SMART Innovation Program supports CTSA
Program Goals by (1) developing, demonstrating, and disseminating an operational innovation that improves
the efficiency and effectiveness of clinical translational, (2) a structured, participatory method for promoting
partnerships and collaborations to facilitate and accelerate translational research projects local, regionally, and
nationally, and (3) creating and providing this with an explicit emphasis on addressing health disparities and
deliver the benefits of translational science to all. More specifically, we build on our collective prior experience
and collaboration combining community based-system dynamics as a participatory method for selection and
tailoring of implementation strategies with a social marketing approach within a novel set-based concurrent
engineering approach borrowed from manufacturing to accelerate translational research and health equity. Our
primary hypothesis is that the integration of participatory system dynamics modeling with social marketing
analysis improves clinical and translational research effectiveness, efficiency, and equity by reducing the
complexity of translational research.
The SMART Innovation program is designed to work with clinical researchers at any stage of the
translational research continuum with an emphasis on the design of implementation strategies that maximize
implementation outcomes of fidelity, reach, and sustainability of clinical interventions to promote health equity.
More specifically, the SMART Innovation program begins with market analysis of the end user of the innovation
(e.g., patient in the case of medication adherence, provider in the case of suicide screening and referral) to
characterize the initial distribution of “demand” for the clinical innovation and its potential impact on reducing
health inequities. This preliminary analysis provides the basis for a 2.5-day participatory group model building
workshop with clinical researchers, implementation researchers, and end-users (or proxies, e.g., a patient
navigator, advocate) to conceptualize the implementation context as a system, select and tailor implementation
strategies, and refine an implementation. The program then supports the refinement of the analysis through a
second phase of marketing analysis, leading to a more efficient translation of clinical and community
innovations to improve health outcomes and health equity.

Public health relevance
PROJECT NARRATIVE The goal of the Systems Marketing Analysis for Research Translation (SMART) Innovation Program is to accelerate the translation of known, effective interventions into practice and at a speed and reach that can significantly close regional gaps in health. The project does this by engaging clinical research teams in a structured process for understanding and identifying the drivers of health outcomes.